Age-related Cognitive Changes: Effects of Combined Flavonoid Intake and Physical Exertion Mediated by the Gut Microbiome

Age-related cognitive changes: Effects of combined flavonoid intake and
physical exertion mediated by the gut microbiome
Age-related cognitive changes can be the first indication of the progression to dementias, such
as Alzheimer's. These changes may be driven by a complex interaction of factors including diet,
activity levels, genetics, and environment. Recent in vivo experiments and human clinical trials
have shown that flavonoid-rich foods can inhibit neuroinflammation and enhance cognitive
performance. Improved cognition has also been correlated with a physically-active lifestyle, and
with the functionality, composition, and diversity of the gut microbiome. Research has
established that 1) the great majority (+90%) of dietary flavonoids are biotransformed into
phytoactive phenolic metabolites at the gut microbiome level prior to absorption, 2) prebiotic-
like dietary flavonoids alter microbiota profiles, functionality and diversity, 3) health-relevant
outcomes from flavonoid ingestion may only be realized in the presence of a robust microbiome
and 4) physical exertion (moderate aerobic exercise) dramatically accelerates the uptake of these
gut-derived anti-inflammatory and immunomodulatory phenolic metabolites into circulation.
This project's hypothesis is that the combination of flavonoid-rich diet and routine physical
activity may potentiate cognitive benefits and reduce cognitive decline in an aging population,
via mechanisms mediated by the gut microbiome. Aim 1 will examine the effects of routine
flavonoid-rich blueberry intake (12-weeks), combined with or in the absence of regular
moderate exercise, on cognitive function in a clinical population of older participants identified
as experiencing age-related cognitive changes. Aim 2 will investigate, using shotgun
metagenomics, the extent to which observed cognitive function is associated with intervention-
induced changes in the microbiome and explore synergies. This Aim will leverage a unique and
extensive in-house library of gut-derived phenolic metabolite standards. In Aim 3, the ability to
abrogate the microbiome in test animals, unlike humans, will clarify its role in linking diet and
physical exertion to cognition in aging brains. A mouse cognitive decline model employing
antibiotics will isolate and interrogate the role of the microbiome as a mechanistic target by
which dietary flavonoids and/or exertion improve cognitive outcomes. We will humanize the
mice using fecal samples collected at baseline from human clinical subjects exhibiting age-
related cognitive changes. The overall result of this project will determine how dietary
flavonoids (e.g. berries) and moderate physical exertion, as reasonable diet and lifestyle
modifications, can impact cognitive change in the aging population via the gut microbiome.

Public health relevance
Project Narrative Our goal is to validate an age-appropriate and achievable lifestyle modification to proactively protect cognitive health in an aging population. We hypothesize that the cognitive benefits boosted by dietary flavonoids (e.g. from berries) and by physical exertion (movement) are both mediated by the diversity, functionality and composition of gut microbiota, which control delivery of cognition-relevant phenolic metabolites into human circulation. This project will explore the dynamic interplay between physical activity-driven, microbe-mediated flavonoid biotransformation into bioactive phenolic metabolites, and age-related cognitive function.